Improving Diagnostics and Neurocognitive Outcomes in HIV/AIDS-related Meningitis

ABSTRACT
Central nervous system (CNS) infections are common across all ages in Africa in people with or without
HIV-infection. In people with HIV, cryptococcal meningitis has historically been the second most common
AIDS-defining illness in Africa and the most common cause of adult meningitis in Africa overall. The next most
common cause of meningitis is likely TB meningitis, although CSF diagnostics are challenging. With the
widespread availability of antiretroviral therapy (ART), long term survival in persons living with AIDS and CNS
infections should be possible, but delayed or inaccurate diagnoses and limited therapeutic options contribute to
poor outcomes. In the era of widespread ART access, more people are presenting with CNS infections
unmasked after starting ART or with virologic failure, yet their epidemiology and outcomes are unclear.
We propose to continue a prospective cohort study to enroll >1000 new persons presenting with CNS
infections and HIV in Uganda. We will use point-of-care and molecular diagnostics to rapidly determine the
etiologies of CNS infections, with a specific focus on optimizing and validating new diagnostic tests, such as a
semi-quantitative cryptococcal antigen (CrAg-SQ) lateral flow assay and Xpert-HR Host Response gene
signature for active tuberculosis. Second, we will investigate a new oral antifungal, oteseconazole, conducting
a phase II randomized proof-of-concept clinical trial to investigate microbiologic activity in cryptococcosis.
Oteseconazole is a tetrazole that is >100-fold more active in vitro than fluconazole. Third, we will determine the
impact of oteseconazole on neurocognitive performance vs standard-of-care. Our Specific Aims include:
1. Determine the etiology of CNS infections in Africa among HIV-positive adults through use of a stepwise
diagnostic algorithm, accounting for HIV therapy status.
2. Determine if adjunctive oteseconazole has greater in vivo activity than adjunctive fluconazole + flucytosine
when added to single-dose IV liposomal amphotericin B in HIV-associated cryptococcal meningitis.
3. Determine if oteseconazole is associated with better quantitative neurocognitive performance Z-score
(QNPZ-8) at 3-months after cryptococcal meningitis compared to standard fluconazole consolidation.
Hypotheses:
1. We hypothesize that in the ART era, cryptococcal and TB meningitis will remain the two most common
etiologies of meningitis in an HIV-positive population, with the majority now presenting ART-experienced.
2. We hypothesize oral oteseconazole will have a superior quantitative rate of CSF sterilization when added to
IV amphotericin in comparison to adjunctive fluconazole + flucytosine. We hypothesize oteseconazole will
have a lower incidence of culture-positive relapse through 1 year of follow up than standard fluconazole.
3. We hypothesize oteseconazole will have better QNPZ-8 at 3-months vs those randomized to fluconazole.

Public health relevance
8. Project Narrative In Africa, meningitis ranks second among HIV/AIDS defining illnesses, contributing approximately 15- 20% of AIDS-related mortality. Historically, Cryptococcus and TB were the two most common causes of meningitis in Africa. However, with the widespread rollout of HIV therapy, the epidemiological landscape is likely shifting. This project aims to define the current epidemiology, validate novel diagnostic tests, and carry out a mechanistic proof-of-concept trial for a new antifungal drug to treat fungal meningitis.